Administrative Core

CCSG ADMINISTRATION ABSTRACT The Roswell Park Comprehensive Cancer Center Administration provides the financial and administrative resources, guidance, processes, and expertise to enable Roswell Park to achieve its mission to eliminate cancer's grip on humanity by unlocking its secrets through personalized approaches and unleashing the healing power of hope. Administration is led by Dale Henry, MBA, AD Administration and Judith Epstein, CCSG Administrator, with 50 FTE staff from across the cancer center. Staff are responsible for programmatic initiatives, shared resources and evaluation activities, ensuring appropriate infrastructure is in place for governance and financial management. Administration coordinates membership and manages all research space and equipment on campus, renovations and laboratory moves; interacts with marketing, philanthropy and information technology to benefit faculty and staff. Oversight of the 17 CCSG and Institutionally-supported shared resources is done by Administration team members. Communication initiatives include updating the web pages, funding and science quarterly newsletters distributed to all CCSG members. Administration successfully facilitated 162 new faculty recruits; space and facilities management for the Community Outreach and Engagement (COE) building and Cell Therapy Center; and integration of shared resources. Faculty Development programs blossomed with Administration supporting the Cancer Research Training and Education Coordination (CRTEC) team. Team science proposals involved planning and coordination across multiple departments and institutions. Administration implemented EVAL to assist with CCSG membership and publication management while also investing in InfoReady for internal pilot project application receipt and review processes for philanthropic and CCSG Developmental Funds distribution. Roswell Park finalized the strategic plan in 2023 focusing on five strategic objectives that include: (1) to advance the future of patient centered care, (2) to maximize community impact, (3) to accelerate breakthrough discoveries, (4) to promote a culture of fairness, accountability, integrity and respect, and (5) to enhance the education of faculty, trainees and staff. In 2022-23, the internal strategic planning process led to the dissolution of the Genetics and Genomics program and members redistributed to other programs. Future directions for CCSG Administration include leadership development, ensuring continuity in CCSG knowledge, expansion of IT custom-built applications including nSightTM, RevealTM and ImagineTM. Further, we are exploring new electronic research administration systems to further enhance sponsored research fiscal management across the center.